The effects of BTNL2 on experimental autoimmune encephalomyelitis

Project Summary
Multiple sclerosis (MS) is an autoimmune disease of the central nervous system and remains a major cause of
disability in both young and older populations. Experimental autoimmune encephalomyelitis (EAE) is the most
commonly used animal model for MS, and is induced by immunization with disease-causative self-antigens
such as myelin oligodendrocyte glycoprotein (MOG). It is generally believed that MS is mediated by immune
responses, especially T cells, against myelin antigens, followed by neurological impairment. T cells are the
major component of the immune system, and are regulated by stimulatory and inhibitory molecules. Among the
T cell regulators, the B7 family members are of central importance. In the past several years, several new
drugs that target the B7 family members including PD-L1/PD-1 and CTLA-4 have been approved by the FDA
for the treatment of autoimmune disease and cancer. Butyrophilin (BTN) and BTN-like (BTNL) molecules
share sequence, structural, and functional similarity with the B7 family, thereby being considered as extended
B7 family members. BTNL2 is a member of the BTNL family. It has been reported that BTNL2 mutations are
associated with inflammatory autoimmune diseases and that BTNL2 protein can inhibit T cell functions in vitro.
The BTNL2 receptor is expressed on activated T cells, and seems to be distinct from the receptors for other B7
family members including CD28, CTLA4, ICOS, BTLA and PD-1. We have shown that recombinant murine
BTNL2-IgG2 Fc (mBTNL2-Ig) fusion protein can inhibit the proliferation, activation and cytokine production of
autoreactive T cells from NOD mice in vitro. We were the first to show that in vivo administration of mBTNL2-Ig
attenuates type 1 diabetes and graft-versus-host disease in mice, which was associated with its ability to inhibit
the proliferation, activation and cytokine production of effector T cells, but increase the generation of regulatory
T cells. Previous studies of BTNL2 by us and other groups used a mouse form of protein. However, whether
human BTNL2 (hBTNL2) has similar functions has not been determined. In this proposal, we will first produce
hBTNL2-Ig protein, and determine its ability to inhibit both mouse and human T cell proliferation and activation
in vitro. Since MS is a T cell-mediated autoimmune disease and mBTNL2-Ig can inhibit T cell functions, we
hypothesize that administration of either mBTNL2-Ig or hBTNL-2 protein can ameliorate EAE in mice. This
hypothesis will be tested in Aim1. Although the BTNL2 receptor is distinct from the receptors for existing B7
family members, the nature of the receptor remains unknown. In Aim 2, we plan to identify the receptor by new
or traditional approaches. These exploratory studies, if successful, have the potential to lead to a new
approach to prevent and treat MS. The identification of the BTNL2 receptor will allow for better understanding
of how BTNL2 inhibits T cell functions, and facilitate the therapeutic development of BTNL2 in the treatment of
cancer and autoimmune disease.

Public health relevance
Project Narrative Experimental autoimmune encephalomyelitis (EAE) is a common animal model for multiple sclerosis (MS) that is mediated by immune responses, especially T cells, against myelin self- antigens, followed by neurological impairment including the destruction of the myelin sheath and axonal loss. We and others have shown that mouse butyrophilin-like molecule 2 (BTNL2) can inhibit T cell proliferation, activation, and inflammatory cytokine production in vitro and T cell immune responses in vivo. This R21 grant is to investigate the ability of both mouse and human BTNL2 protein to prevent and treat EAE in mice and to identify the BTNL2 receptor.